Administrative Core

Project Summary – Administrative Core
Summary
The Administrative Core is designed to provide scientific leadership, effective communication, and an
administrative support structure to ensure the coordination of all PDTC activities. The essential services
provided by the Core include: administrative support for all of the investigators in each project and core;
scientific oversight and progress review for each project; coordination of selection processes for Pilot Studies
and integration of these investigators and their projects into full PDTC program as they evolve; fiscal and
financial management and oversight for all components of the PDTC; and organization and communication of
all PDTC meetings and activities. The Administrative Core is also responsible for all interactions with the NCI
staff, including scientific and administrative.
The overall objectives of the Administrative Core are to:
1. Establish and maintain an administrative structure to provide support for and management of all PDTC
activities.
2. Foster an environment to maximize collaborative and translational research among PDTC investigators
between Wistar, MD Anderson, and Penn and between other PDTC/PDXNet and NCI initiatives.
3. Ensure compliance with all institutional, governmental, and NCI regulations and policies.
.